Approaches for PAH Source and Fate Determination in Exposures

PROJECT SUMMARY – ANDERSON PROJECT
The first aim of this project is to develop a generalizable approach to discover the sources of polycyclic aromatic
hydrocarbons (PAHs). This aim addresses SRP Mandate #3: Develop methods and technologies to detect
hazardous substances in the environment. By helping remediators and risk assessors to identify the sources of
PAHs, we will enable them to understand the systemic behavior of a polluted site and thereby to optimize their
plans to remediate the site and to evaluate the impact of the remediation.
The second aim of this project is to determine whether alkylated PAHs (a-PAHs) move through the environment
in the same way as their parent compounds. This aim addresses SRP Mandate #2: Develop methods to assess
the risks to human health presented by hazardous substances. The proposed work will help scientists and policy
makers to understand the real-world human exposures of these recently discovered prevalent chemicals.
The third aim of this project is to predict the concentrations of a-PAHs in crayfish and shellfish based on
concentrations measured by passive sampling devices in the surrounding water. This aim addresses SRP
Mandate #1: Develop advanced techniques for the detection, assessment, and evaluation of the effects on human
health of hazardous substances. This research will give Superfund managers and public health officials a
rational, low-cost basis for limiting access to fishing and for prioritizing Superfund sites for remediation.
We propose to learn to associate any given environmental PAH with a legacy source (such as a specific Superfund
site) or a contemporary source (such as automobile traffic, floods, or wildfires). To this end, we will couple
stationary passive sampling devices with analytical tools (gas chromatography combustion isotope ratio mass
spectrometry, or GC/C/IRMS instruments) that can measure the ratios of stable isotopes of carbon and
hydrogen. Those ratios will serve as “fingerprints” or forensic signatures of specific PAH sources.
We propose to learn to identify the sources of PAHs to which individual people are exposed. To this end, we will
couple passive sampling wristbands with the same GC/C/IRMS instruments.
We will initiate the research plan for each of the center’s overall integrative research goals by identifying PAHs
in air, water, and sediment at Superfund sites and determining which of those PAHs are present in the highest
concentrations. We will also collaborate with the Community Engagement Core and the Research Translation
team to translate our research products, such as computer models that a) predict PAH toxicity, adverse impacts,
AhR binding, gene expression response, and carcinogenicity on the basis of chemical structure and tissue dose,
b) predict whether a given PAH mixture will exhibit additive toxicity, and if so, which components in the mixture
are likely responsible for the observed effects, and c) predict synergistic and / or antagonistic toxicity in PAH
mixtures via a mechanism involving PAH metabolites.

Public health relevance
PROJECT NARRATIVE – ANDERSON PROJECT The Anderson Project will provide information about PAH sources that will enable Superfund site managers to select the most environmentally sound and cost-effective remediation strategies and to evaluate the impacts of those strategies. We will provide information about PAH sources that will help communities to connect their personal exposures to specific indoor and outdoor features and to develop strategies that minimize their exposures. We will develop the ability to predict the concentrations of alkylated PAHs (a-PAHs) in crayfish and shellfish on the basis of measured concentrations in the surrounding water, thereby helping communities to minimize dietary risks, helping policy makers to evaluate the purity of water and the human risks from fish consumption, reducing the need to destroy organisms in order to measure a-PAH contamination, and reducing the time and expense associated with collecting crayfish and shellfish with the required spatial and temporal resolution.